Training in Basic and Translational Digestive Sciences

ABSTRACT
This application seeks to renew the NIH T32 Training in Basic and Translational Digestive Sciences that is
currently in its 10th year. The University of Michigan has a superb history of training in gastrointestinal
sciences over the last several decades, including both physician and non-physician scientists. In 2012 we
initiated a training program that focused on training postdoctoral clinical fellows (MD, MD/PhD) together with
predoctoral PhD candidate scientists interested in basic and translational digestive sciences. The Training
Program includes 26 NIH-funded faculty mentors, including 12 clinically active physician scientists and 14 non-
clinical faculty members, who come from clinical and basic science departments: Internal Medicine (13),
Molecular & Integrative Physiology (6), Pathology (3), Microbiology & Immunology (3), and Surgery (1). Our
program consolidates the major investigators who are conducting gastrointestinal basic and translational
research at the University of Michigan Medical School into a strong core of mentors for the training of physician
scientists and biomedical investigators interested in a research career in gastrointestinal science. Our group of
26 training program faculty are also members of the Michigan Digestive Diseases Core Center funded by NIH
(P30 DK34933) since 1986 and bring a long history of collaboration and team science. Our T32 training
program focuses on three thematic areas that provide exceptional cross-disciplinary collaboration amongst the
participating faculty: 1) mechanisms of cell fate, plasticity, regeneration, and transformation; 2) systemic,
cellular, and nutrient metabolism; 3) immune and inflammatory responses to host-environment-microbial
interactions. Continued support is requested for 3 predoctoral trainees seeking PhDs in one of a number of
disciplines that range from Physiology, Microbiology & Immunology, to Cell & Molecular Biology, and for 2
postdoctoral Gastroenterology Fellow trainees. The Program, co-directed by Chung Owyang, MD (Division of
Gastroenterology, Department of Internal Medicine) and Linda Samuelson, PhD (Department of Molecular &
Integrative Physiology), includes a weekly seminar series in GI science (both internal and external speakers),
trainee research presentations, training in responsible conduct of research and research reproducibility, and
strong mentoring and career development guidance. Trainee research will be supported by more than $20
million of annual research funding awarded to the training faculty combined with substantial institutional
support to directly support the trainees and the Program. The combined mass and diversity of available
resources, our past training record, and the demonstrated excellence of the training faculty provide strong
evidence that this program will continue to be highly successful in training the next generation of investigators
interested in basic and translational digestive sciences.

Public health relevance
PROJECT NARRATIVE There is a clear need to train academic physicians and scientists to perform research in gastroenterology in order to sustain the future generations of scientists and to maintain our edge in scientific excellence and innovation worldwide. This proposal puts together a training program which consolidates the major investigators conducting gastrointestinal research at the University of Michigan into a strong core of mentors to address this unmet need. Support is requested for 2 postdoctoral trainees and 3 predoctoral candidates selected from the University of Michigan program in biological sciences.